The neural bases of placebo effects and their relation to regulatory processes

Placebo treatments can induce clinically significant benefits across a variety of disorders. These
benefits are not due to the treatment itself, which is pharmacologically and physically inert, but to
the effects of the interpersonal context and treatment cues on the patient’s brain. This R01
renewal funds an ongoing program of research that has made fundamental contributions to the
neuroscience of placebo effects. Neuroscientific studies from our group and others have
established that placebo treatments influence cortical-subcortical brain pathways and
neurochemical systems related to the endogenous control of pain, threat, and other affective
responses. Placebo treatments influence internal conceptual models of the situation and its
impact on the self, interacting with learning systems to create stable patterns of affective reactivity.
These systems are also central to symptom progression across mental health, substance use,
and other brain disorders. Understanding placebo effects will thus help improve psychological
and neurological treatments across disorders. Our previous work identifies several significant
gaps important for connecting placebo research to mental health. First, not all placebo treatments
influence affective brain processes in fundamental ways, and it is critical to identify the factors
that underlie deep and durable influences. A key may lie in the nature of the interpersonal
interactions involved. In spite of their critical importance, few neuroscientific studies investigate
the qualities of the care provider and the provider-recipient match that lead to powerful therapeutic
effects. Second, treatments must be studied at a computational level, incorporating models of the
dynamic learning processes that create robust and durable effects. Third is a need to investigate
brain pathways across multiple types of affect relevant for mental health. In Aim 1 (Studies 1-3),
we develop an interpersonal placebo paradigm that allows for the study of provider-recipient
resonance. We probe placebo effects across multiple types of affect, including pain, fear, and
cognitive performance under threat using fMRI (Study 1), autonomic responses (Studies 1 and
2), and some of the first direct neural recordings of interpersonal influence in humans (Study 3).
In Aim 2, we extend this work to consider interactions with the recipient’s mental state. We use
fMRI to compare and study the interaction between placebo suggestions and mindful acceptance
(Study 4), testing the hypothesis that a state of relaxed, mindful awareness will increase
receptivity to placebo suggestions and potentiate placebo effects. Across studies, computational
models test whether placebo treatments, and their enhancement by interpersonal processes,
influence learning dynamics in a way that creates self-reinforcing effects resistant to extinction.

Public health relevance
Project narrative Though placebo treatments are pharmacologically inert, they induce active neurobiological processes related to patients’ expectations, learned associations, perceived care and support, and hope for the future. Studying placebo treatments provides a window into these crucial context variables that will help understand vulnerability and resilience to mental health disorders and beyond. This project continues a successful program of research on the brain mechanisms of placebo effects, taking the work in new directions critical for understanding mental health.